Investigating VICE domain functions tied to altered ribosome localization and translational flux during HSV-1 infection

Herpes simplex virus type-1 (HSV-1) initiates cell-wide competition for essential resources and cellular factors,
remodeling the nucleus by requisitioning histones and RNA polymerases, reprogramming splicing complexes,
and dissolving the nucleolus, a site responsible for the bulk of ribosome biogenesis. To globally capture protein-
protein interactions underlying this remodeling we developed and implemented a hybrid mass spectrometry
approach using thermal proximity coaggregation profiling with nuclear-cytoplasmic fractionation. Analysis
revealed the accumulation of dozens of cellular chaperones in the nucleus throughout infection, suggestive of
the formation of Virus Induced Chaperone Enriched (VICE) domains. VICE domains are a unique, yet nebulous
feature of HSV-1 infection whose overall composition and functional significance are not well understood. We
therefore leveraged our subcellular thermal profiling results to gain further insight into the composition and
properties of VICE domains. Through examination of proteins exhibiting HSV-1 dependent interactions with
chaperone proteins in the nucleus, we discovered that ribosome biogenesis factors are recruited to VICE
domains, a finding we expanded upon to identify VICE-driven recruitment of both nascent nuclear and mature
cytoplasmic ribosomal proteins as well as ribosomal RNA. This correlated with substantial remodeling of
ribonucleoprotein signatures within the nucleus and intense concentration of nascent proteins within VICE
domains. These preliminary findings implicate ribosome remodeling, translational capacity, and altered
proteostasis in the functional significance of VICE domains. My central hypothesis is that subcellular rerouting of
translational flux via VICE domains is an evolved strategy to outcompete host cells for proteostatic resources. In
Aim 1, I will incorporate orthogonal methods in proteomics and transcriptomics to measure VICE domain
components in a cross-sectional and flux-dependent manner, using this information for bioinformatic analysis to
define structure or sequence-specific drivers of VICE domain recruitment and testing whether VICE
sequestration of proviral factors can synthetically restrict HSV-1 replication. In Aim 2, I will employ a
complementation strategy modulating VICE domain formation to interrogate how VICE-driven regulation of
proteostasis contributes to HSV-1 replication and spread. Overall, this proposal takes an integrated approach
using proteomics, transcriptomics, machine learning-assisted bioengineering, confocal microscopy, and virology
to elucidate the functional significance of a unique and under-characterized feature of HSV-1 biology with
implications for fundamental biological processes in translation and proteostasis. This work will take place at
Princeton University in the laboratory of Dr. Ileana Cristea, an internationally renowned expert in proteomics and
virology with a strong track record training successful academic scientists. My professional and research
development will by supported by career development and writing workshops offered at Princeton, presentation
of research at conferences, and preparation of manuscripts.

Public health relevance
PROJECT NARRATIVE Herpes simplex virus type-1 infection induces substantial nuclear remodeling, one feature of which is the formation of Virus Induced Chaperone Enriched (VICE) domains, distinct structures whose overall composition and functional significance are not well understood. We discovered that VICE domains recruit ribosome biogenesis factors, subunits, and RNA. This proposal will build upon our findings, linking VICE domain regulation of proteostasis through the sequestration of translation machinery and chaperones to drivers of viral fitness.